Longitudinal Study of HIV and Aging in Brazil

PROJECT SUMMARY
This study will investigate the clinical outcomes and immunometabolism consequences associated with gut
microbiome profiles in older people living with HIV. Adverse shifts in the gut microbiome have been associated
with chronic non-communicable diseases (particularly cardiovascular disease [CVD]) and HIV infection.
Composition of the gut microbiome is also associated with measures of healthy aging and development of
frailty, sarcopenia, and cognitive decline in aging adults. Our understanding of how the gut microbiome and its
potential immune and metabolic pathways contribute to the excess burden of CVD and geriatric syndromes in
older adults with HIV is incomplete. This data is particularly needed from global settings where differences in
HIV disease history, endemic co-infections, and social and economic settings shape the microbiome
composition. Using previously collected samples from a large, longitudinal cohort study of aging adults with
HIV in Brazil, this study will examine (1) the microbiome composition and functional profiles associated with
CVD and geriatric syndromes and (2) the microbiome metabolites associated with inflammatory pathways
which contribute to those conditions. Leveraging the rich clinical and social data collected in the Longitudinal
Study of HIV and Aging in Brazil (R01AG071439), we will first characterize the gut microbiome composition of
all participants (n=700) to examine how the microbiome profiles predict prevalent CVD and geriatric
syndromes, after accounting for confounders such as age, HIV disease biomarkers (including CD4 cell count
nadir), presence of chronic co-infections, and socioeconomic factors. In a nested cohort (n=90 participants),
we will examine more specifically whether the presence of pro-inflammatory microbiome species predicts
prevalent CVD and geriatric syndromes using cutting-edge, molecular genomic approaches. Finally, to explore
potential immunometabolism mechanisms of gut dysbiosis and CVD and geriatric syndromes, we will measure
whether alterations in plasma microbiome metabolites (amino acids and short chain fatty acids) predict
elevations in specific inflammatory pathways associated with CVD and geriatric syndromes in adults with HIV.
Building upon a robust, international collaborative study exploring how chronic co-infections affect aging
outcomes in adults with HIV, this supplemental study adds the important examination into the role of
commensal microbes. The supplemental study will be led by key study co-investigators and further enrich the
collaborative network across the hemisphere.

Public health relevance
PROJECT NARRATIVE Through its effects on the human immune system and metabolism, the gut microbiome is increasingly recognized as a contributor to chronic diseases (particularly cardiovascular disease) in aging adults, including those living with HIV. Additional understanding of how the gut microbiome impacts risk for geriatric syndromes, including frailty and cognitive decline, in aging adults with HIV is urgently needed. Assessing the gut microbiome profiles associated with cardiovascular disease and geriatric syndromes and investigating the inflammatory and metabolic pathways affected by the gut microbiome will inform future interventions to improve the quality of life and long-term outcomes of older adults living with HIV.